Hyperpolarized MRI Technology Resource Center

Administration Project Summary/Abstract
The Hyperpolarized MRI Technology Resource Center (HMTRC) is designed to be timely, nimble and highly
productive in the development of new hyperpolarized (HP) MR instrumentation, techniques, acquisition and
analysis software through push-pull interactions with Collaborative Project (CP) investigators. In parallel, another
key goal of the center is to disseminate these newly developed technologies to the Service Project (SP)
Investigators for extramural feedback and to the general scientific community through the new website,
symposia/seminar, monthly newsletter, annual HP MR Technology Workshops, and hands-on training. In order
to accomplish all these goals and functions, a carefully-constructed administrative plan has been developed &
refined over the past 10 years, with a clearly defined, but dynamic structure that can be modified to meet new
challenges and changing collaborative, service, training and dissemination needs. This has required a detailed
organizational structure to enable “team decision-making”, so that each member of the team can provide their
specialized input for optimal technology development and translation to address unmet scientific and/or clinical
needs.
The HMTRC administrative structure and implementation have evolved considerably since the original
submission as the interactions and complexity of the P41 have increased dramatically over the past ten years.
These improvements have also benefited from great institutional support, input from many experienced sources
including the external advisory committee (EAC), leading experts in HP technology, the HP Radiologist
Leadership & Translational Advisory committees, NIBIB Program Staff, and interactions with other P41 centers.
The HMTRC administrative infrastructure now extends nationally to provide information, dissemination of novel
technologies to CPs, SPs, and other investigators conducting HP 13C MRI preclinical and clinical research. As
stated in their attached report: “The EAC … is unanimous in their assessment that the HMTRC is high functioning
as an NCBIB. The HMTRC has led the nation (and the world) in the development and translation of HP MRI
through a unique combination of skills, expertise, instrumentation, environment, clinical engagement, and
industry engagement, which simply does not exist elsewhere. The HMTRC will continue to serve as a critical
national resource through the next funding cycle as the field of HP MRI expands and matures, particularly with
the clinical translation of new HP agents, and more sites engaging in research involving human subjects. The
restructured Center benefits from clear and enhanced synergy between all TR&Ds and Collaborative Projects
that are more broadly geographically distributed”.